Publication of the SAGE Report

Publication of the SAGE Report and distribution on the report “Shades of Gray: A Cross-Country Study of Health and Well-Being of the Older Populations in SAGE Countries, 2007-2010.”